Molecular Mechanisms in Membrane Bioenergetics, Transport and Signaling

AREA 1. MECHANISMS AND ORGANIZATION OF MEMBRANE PROTEINS

The goal in Area 1 has continued to be advancing our understanding of the mechanisms that control the permeation of ions and other substances across membranes, both through passive-diffusion channels and active transporters. Our studies have focused on the human lysosomal channel TMEM175, which is implicated in Parkinson's disease; on MscS, a prototypical mechanosensitive ion channel; and on YfKE, a proton-driven calcium transporter. These multidisciplinary studies have revealed novel insights into the spontaneous emergence of biological function at the molecular level, from the interplay between protein structures, their substrates, and their environment.

AREA 2. DEVELOPMENT OF MOLECULAR SIMULATION METHODS

In Area 2 we have continued our efforts to develop and disseminate novel methodologies for molecular-simulation and data analysis - particularly those with which to examine the mechanisms of membrane proteins as well as the factors that control their membrane organization and regulatory interactions with the lipid bilayer.